Understanding and Targeting the Pathophysiology of Youth-onset Type 2 Diabetes

Youth-onset type 2 diabetes (YO-T2D) is increasingly prevalent in parallel with the obesity epidemic, yet effective treatment and prevention strategies are limited. The physiologic increase in insulin resistance occurring during puberty, in combination with obesity-related insulin resistance, enhances the risk of T2D. Yet, it remains unclear why some youth progress through puberty with intact β-cell function, while others do not, despite similar phenotypic and metabolic characteristics. More information is needed regarding the unique events during puberty to better understand 1) the basic pathophysiology of glucose control, insulin sensitivity, β-cell function, and T2D risk in youth, 2) differences among girls and boys, populations at highest risk, and urban and rural geographies, and 3) the potential contribution of other risk factors including psychological, behavioral, and social and external contexts. Importantly, this research needs to address the timeline of pathophysiology and progression from normoglycemia or prediabetes to YO-T2D. The DISCOVERY of Risk Factors for Type 2 Diabetes in Youth (DISCOVERY) study provides a unique opportunity to characterize the risk progression profile and mechanisms underlying the development of YO-T2D, and evaluate the effects of modifiable and non-modifiable risk factors. Ultimately, the results of this study will establish a basic pathophysiology to inform future studies aimed at achieving target glycemia, improving insulin sensitivity, preserving β-cell function, and/or preventing YO-T2D. To address this goal, DISCOVERY will recruit, enroll, and follow a nationally-representative cohort of 3,600 at-risk obese youth in early puberty; extensively phenotype them as they transition through puberty; and characterize the course of decline and dysfunction in pathophysiological indicators that lead to YO-T2D. The expected duration of the DISCOVERY is 5 years, including planning, recruitment, follow-up, analysis, and reporting. In addition, DISCOVERY will store longitudinal biospecimens and genetic material with the intention of acquiring additional ancillary funding to pursue analysis of emerging indicators. The Phoenix site which, includes Arizona State University and Phoenix Children’s has experience in multicenter and diabetes-related investigations and will contribute to DISCOVERY through the recruitment of approximately 240 at-risk youth, implementation of the IRB-approved consensus protocol, participation on DISCOVERY committees, and collaboration on the analyses and dissemination of the findings from DISCOVERY.

Public health relevance
Youth-onset type 2 diabetes (YO-T2D) is increasingly common and parallels the obesity epidemic, yet effective treatment and prevention strategies for at-risk children are extremely limited. The DISCOVERY of Risk Factors for Type 2 Diabetes in Youth study will successfully recruit a cohort of pubertal youth at-risk for developing prediabetes and diabetes, deeply phenotype them through puberty, and contribute to a better understanding of the pathophysiology and epidemiology of YO-T2D. The Phoenix site through collaboration with the other DISCOVERY sites and the Biostatistics Research Center, will recruit the largest cohort of youth at-risk for YO-T2D, explore potentially modifiable risk factors for disease onset, and determine therapeutic targets for future interventions to prevent this disease. Modified Specific Aims The obesity epidemic in the U.S. has resulted in the increasing prevalence and incidence of prediabetes and type 2 diabetes (T2D) in youth. Insulin resistance and β-cell dysfunction underlie the pathogenesis of prediabetes and T2D. Hormonal and metabolic changes occurring during puberty are typically associated with temporary changes in insulin resistance and β-cell response, which, when coupled with other factors (e.g., obesity, sedentary lifestyle, psychological, behavioral, and social and external context), make puberty an especially vulnerable period for progression to prediabetes and youth-onset T2D (YO-T2D). With limited effective treatment options, additional research is needed to identify youth at highest risk, deepen our understanding of the relationship between pubertal stages and dysglycemia, discover novel potential moderators and mediators, and determine how to stop progressive β-cell deterioration. Thus, with more than 18 million obese youth in the U.S. at an increased risk for YO-T2D, the objective of the DISCOVERY of Risk Factors For Type 2 Diabetes in Youth (DISCOVERY) study is to develop more precise early recognition of which youth are truly at-risk for developing YO-T2D, identify determinates of progression from normal glucose tolerance or prediabetes to T2D, and increase the overall understanding of the physiologic and epidemiologic drivers of YO-T2D. DISCOVERY will inform targeted prevention approaches and guide the development of more effective strategies to achieve glycemia targets and preserve β-cell function in at-risk youth. The Phoenix Site research team has experience in multicenter research and diabetes-related investigations, including an NIDDK-funded study testing a family-based diabetes prevention intervention for high-risk families (R01DK107579). We will contribute to DISCOVERY through the recruitment of approximately 240 at-risk youth from our clinical populations which include large numbers of children and adolescents with obesity and prediabetes. We will implement the IRB-approved consensus protocol supported through institutional resources and infrastructure including a clinical research unit staffed by trained nurses and phlebotomists with pediatric research experience. We will participate in DISCOVERY committees as we have done with other NIH-funded consortia such as the NHGRI-funded eMERGE Network. To accomplish the goals of DISCOVERY (RFA-DK-21-003), we propose the following Specific Aims: Specific Aim 1: To recruit a large cohort of youth at-risk for T2D as they transition through puberty. In collaboration with the other DISCOVERY sites, we will recruit 3,600 youth, aged 9-14 years at enrollment to be a representative cohort of boys and girls, populations at highest risk, and urban and rural geographies across research sites in the U.S. Youth will be overweight or obese (BMI ≥85th percentile for age) and have evidence of dysglycemia with an HbA1c range from 5.5-6.4% at screening. Through annual and mid-year visits, longitudinal assessments of demographics, anthropometrics, blood pressure, and medical history will be performed. Local and central stakeholders will play an active role in the study and provide feedback during follow-up. Specific Aim 2: To identify the physiologic drivers and other determinants of progression to T2D by charting the course of changes in glycemia, β-cell function, and insulin sensitivity during this critical period of maturation and inform approaches for identifying which youth are at highest risk of developing T2D. The primary endpoint of DISCOVERY is the development of T2D, as defined by an HbA1c ≥6.5% at an annual or mid-year visit, followed by a confirmatory HbA1c ≥6.5% collected within 2 weeks of the first value. HbA1c, continuous glucose monitoring, and frequently-sampled oral glucose tolerance tests are measures of glycemia captured longitudinally. Major secondary endpoints include intermediary changes in glycemia, β-cell function, insulin sensitivity, and free fatty acid flux along the spectrum of normal glucose tolerance to impaired glucose tolerance to T2D. DISCOVERY will create a biobank of samples with associated phenotypic data to allow DISCOVERY investigators to perform analyses to identify risk factors for progression to T2D. Specific Aim 3: To investigate psychological, behavioral, social, and external context factors that mediate or moderate the risk of development of YO-T2D. Standardized and validated age-appropriate questionnaires will be used to assess other potential contributing factors, including psychological concerns, quality of life, stress, risk behaviors, diet, physical activity, sleep, healthcare usage, and neighborhood. Similar to SA1, we will chart the course of change in these assessments over time in relation to emerging dysglycemia and presentation of YO-T2D to determine if baseline status or changes over the course of follow-up alter risk for T2D. Overall, longitudinal assessments of demographics, anthropometrics, blood pressure, and medical history (SA1) coupled with physiologic (SA2) and psychologic, behavioral, social, and external context (SA3) will inform models for early identification of at-risk youth for the development of YO-T2D and identify treatment targets for future intervention studies. The timeline for DISCOVERY is designed with multiple phases. Recruitment, enrollment, phenotypic, and biochemical characterization will occur over the first 5 years. Phase 1 includes 15 months of planning and study start-up, 2 years of recruitment and enrollment, and up to 4 years of follow-up. Toward the end of Phase 1, study investigators will seek supplemental funding to conduct targeted analyses using stored samples during Phase 2 of the study. Future phases or initiatives may leverage the study's infrastructure to conduct additional studies with youth at-risk for T2D.